IMMUNOGENICITY OF RECOMBINANT HEPATITIS B VACCINE IN PREMATURE INFANTS

The aim of this study was to determine the immunogenicity of recombinant hepatitis B vaccine when administered intramuscularly to premature infants. Ninety percent of preterm infants responded to the hepatitis B vaccine when the first dose of vaccine was given just before hospital discharge. This study is now closed, and the data are being analyzed.